Immunesurveillance of Lung Cancer by Natural Killer Cells

Immunesurveillance of Lung Cancer by Natural Killer Cells
Abstract
Lung cancer is the leading cause of cancer related mortality in both men and women in the United States.
Non-small cell lung cancer (NSCLC) constitutes 80% of all lung cancers and immune checkpoint blockade has
emerged as an effective therapeutic strategy, but only 20% of NSCLC patients respond to these agents. Among
veterans both the rate of incidence and the rate of mortality are twice higher than the entire population, making
this an urgent unmet clinical need among veterans particularly for those who do not respond to current therapies.
NK cells are innate lymphoid cells fundamental to host defense against viral infections and malignancies.
In humans, low NK cell cytotoxicity in peripheral blood correlates with increased cancer risk. Conversely, NK cell
infiltration into tumor tissue is associated with better patient prognosis in multiple malignancies, including
NSCLC. Our preliminary data show that depletion of NK cells in a genetic mouse model of lung cancer
significantly promotes tumor progression, increases tumor burden and decreases survival of mice, demonstrating
a critical role for NK-mediated immune surveillance in lung tumorogenesis
Cell adhesion molecule 1 (CADM1) belongs to the immunoglobulin superfamily of calcium independent
cell adhesion molecules, capable of both homophilic and heterophilic interactions. Interestingly, CADM1
expression is frequently lost in 20-40% of non-small cell lung cancers (NSCLC) either by loss of heterozygosity
or promoter hypermethylation. However, the mechanism(s) by which CADM1 regulates tumor progression is not
known. CADM1 is one of seven proteins in mammals that undergoes an unusual glycosylation known as
polysialylation. The other notable Polysialic acid (polysia) carrier is the protein CD56 expressed on NK cells.
Polysia is a unique carbohydrate structure known for its potent anti-adhesive properties preventing two
polysialylated proteins from interacting with each other. On the other hand, a cell surface protein known as
CRTAM (Class-I MHC-restricted T-cell-associated molecule) was identified as the strongest heterophilic binding
partner of CADM1. CRTAM is expressed on activated NK cells and the CADM1/CRTAM axis has been
implicated in immune surveillance.
Our recent study showed that, in cells expressing CADM1, its induction renders cancer cells susceptible
to NK-mediated cytotoxicity. Inhibition of CADM1 expression promoted metastasis by evading NK mediated
immune surveillance. In contrast, restoring CADM1 in cells with promoter hypermethylation was sufficient to
make cancer cells susceptible to NK-mediated toxicity, suggesting that suppressing CADM1 may be an immune
evasive strategy of tumors. Consistently, increased expression of CADM1 directly correlated with prolonged
patient survival and inversely correlated with higher stage and metastatic disease. We show that polysialylation
of CADM1 on tumor cells modulates their susceptibility to NK cells. Based on these observations, we
hypothesize that CADM1 mediates an immunological synapse between tumor cells and NK cells promoting
tumor immune surveillance and its function is regulated by a unique glycosylation modification. Strategies to
enhance CADM1-mediated NK surveillance may be an effective immunotherapy against NSCLC, particularly for
tumors that are CADM1 positive. The three specific aims of this project are: 1) Define the role of CADM1 in the
regulation of lung tumor progression. 2) Determine the mechanism(s) by which CADM1 function is regulated to
modulate tumor immunosurveillance 3) Design and develop CADM1 targeting CAR-NK cells for lung cancer
immunotherapy.

Public health relevance
Among veterans both the rate of incidence and the rate of mortality due to lung cancer are twice higher than the entire population, making this an urgent unmet clinical problem in veterans. This is partly due to higher smoking rates among veterans that can result in higher incidence of NSCLC in this population. Immune checkpoint blockade strategy has emerged as an effective therapy for lung cancer with long lasting clinical benefits. However, only 20% of patients respond to these agents and currently available only to patients whose tumors express checkpoint ligand, PDL1. Therefore, there is an urgent need of alternatives for a large fraction of patients including those that are PDL1 negative. We recently identified a protein called CADM1, expressed on lung tumor cells and render them susceptible to natural killer (NK) cells of the host immune system. This project will investigate the role of this protein in lung tumor immune surveillance, its mechanism of action and will develop a novel NK cell based immune therapy for lung cancer.